Novel Pigment Sensing Pulse Oximeter Technology for Mitigating Racial Bias in Oxygen Saturation Measurements

Abstract
Wearable pulse oximetry sensors are among the most ubiquitous medical technologies used in healthcare.
Clinicians rely on pulse oximeters to monitor patient health during disease states and medical procedures.
However, numerous studies have shown this technology to be racially biased; hypoxemia is three times more
likely to go undetected in patients with dark skin compared to those with light skin. This technological deficit
disproportionately impacts people of color in the United States and contributes to minority healthcare disparities.
The FDA has since issued a safety warning about using pulse oximetry for minority populations. Low blood oxygen
levels can signify serious respiratory illness in a patient and healthcare workers rely on pulse oximeters to
determine what type of care a patient needs. False negative hypoxemia diagnosis can have detrimental
consequences for patient care including increased rates of mortality and organ dysfunction. The widespread and
impactful use of these devices highlights a critical need for innovative technology that improves healthcare equity
and mitigates racial bias in pulse oximetry. Despite well-documented racial biases, a 2022 survey of pulse
oximeter technology found no manufacturers attempting to incorporate novel technology that accounts for
differences in skin tone. The goal of this Phase I project is to develop novel sensor technology for non-invasively
measuring blood oxygen saturation that accounts for the patient’s skin pigment and delivers reliably accurate
oxygen saturation measurements for persons of all skin colors. Our proposed technology incorporates two
sensing modules: a novel skin pigment colorimetry sensor for classifying patient skin tone and an optical
transducer for measuring blood oxygen saturation via the photoplethysmography technique. We will develop a
machine learning algorithm to model and compensate for the effects of skin tone on blood oxygen saturation
measurements. These innovations in technology development and biological signal processing will meet a critical
need for a medical device that provides accurate blood oxygen saturation monitoring for persons of all skin colors.

Public health relevance
Narrative Pulse oximeters are widely used in healthcare for patient monitoring during disease states and medical procedures; yet recent data have shown this technology to have racial bias, with hypoxemia going undetected for more than 1 in 10 individuals with dark skin. Despite calls from the United States Congress and FDA to evaluate this bias and improve current technology, a recent review found no manufacturer incorporating novel technology that accounts for skin pigment into pulse oximeters. The purpose of this work is to develop an innovative pigment-sensing pulse oximeter that delivers reliably accurate measures of blood oxygen saturation for persons of all skin colors, thereby improving healthcare for all and eliminating racial disparities occurring due to current technological limitations.